Data Management and Analysis Core

DMAC Summary
The Data Management and Analysis Core (DMAC) will ensure wide accessibility of the complex and integrated
health and earth science data generated within the Columbia University Northern Plains Superfund Research
Program (CUNP-SRP). These efforts will be guided by an overarching mission to treat and share data
according to the principles of tribal data sovereignty and the research code set in place by our partnering
communities in the Northern Plains. The DMAC will dedicate significant resources to supporting application of
existing analysis methods, developing innovative analysis techniques, and ensuring long-term reproducibility of
results by leveraging statistical and data science expertise. The DMAC is centrally positioned in the CUNP-SRP
and will serve all Projects and Cores, including the Community Engagement Core (CEC) and Research
Experience and Training Coordination Core (RETCC), through three aims. Aim 1 will integrate and enhance
data management, sharing, and interoperability. We will use established capabilities of the Data Management
Unit at Columbia University to develop customized data management and quality assurance plans for each
Project/Core, manage data collection and databases, coordinate and harmonize datasets, and provide for their
efficient querying. The DMAC will create streamlined data communication across Projects and with external
partners and data requestors, following appropriate procedures approved by our partnering tribal communities,
by creating an integrated webpage that provides central access to the databases and offers advanced search
capabilities. The webpage will act as a platform to locate, access, and mine data while meeting the data sharing
requirements of each study. We will also share data via this Database Directory and will work with investigators,
data owners, and governmental or policymaking agencies to locate additional available online data resources.
Aim 2 will expand statistical resources, data analysis capability, and reproducibility tools. DMAC will
provide expertise in established methods for data analysis including statistical and physical modeling. It will also
support development of innovative methods, particularly in complex and high-dimensional data inherent to omics
research and to complex environmental and geospatial research. Additionally, DMAC will develop, test, and
apply robust implementations of new methods for complex data and ensure long-term reproducibility of findings
through containerized analysis pipelines. Aim 3 will educate investigators, trainees, and citizen scientists
in data sovereignty, sharing, management and analysis. DMAC will collaborate with the RETCC to organize
workshops, seminars, and other educational opportunities. Methods, results, and educational resources will be
shared with all stakeholders via CUNP-SRP outreach through the CEC, Admin Core, and including the DMAC
webpage. Procedures established by DMAC will strive to meet the needs of all investigators and partnering
communities, adding substantial value to our collaborations within the CUNP-SRP, across other SRP centers,
and to the wider community.

Public health relevance
Narrative The DMAC will collaborate with CUNP-SPR Project investigators and our partnering communities in the Northern Plains to ensure that all relevant data are clearly organized, well documented, easily accessible and respectful of all aspects of tribal data sovereignty. A user-friendly DMAC web portal on the CUNP-SRP website will allow users with different security levels – public, CUNP-SRP investigators, trainees, and administrators – to search, view, enter, or edit data on individual databases as appropriate. The DMAC will support the application of existing methods and the development of new methods for analysis in service of the CUNP-SRP’s goals, take steps to ensure the reproducibility of all findings, and create educational resources for investigators, trainees, citizen scientists, and community members.